Genetic Analysis of S. Pyogenes Virulence Factors

Grant Number: 2R01AI020723 - 24A2 PI Name: Scott, June R No Text

Public health relevance
Streptococcus pyogenes, the group A streptococcus (GAS) is an important human pathogen that causes many types of disease, ranging in severity from "strep throat" to severe invasive disease and streptococcal toxic shock syndrome. By elucidating the regulation of expression of virulence factors in the GAS, this project will help define the mechanisms the bacterium uses to produce different diseases. We anticipate, therefore, that this work will define new targets for development of therapeutic agents and vaccines.